Molecular details of the IgE antibody response to galactose-alpha-1,3-galactose in alpha-gal syndrome

PROJECT SUMMARY
The IgE molecule lies at the center of the pathogenesis of allergic diseases. In sensitized individuals, re-exposure to the
offending allergen results in IgE engagement, causing Fcε receptor cross-linking and activation of mast cells and
basophils. This triggers the release of mediators into the local tissue, resulting in the vast array of symptoms associated
with allergic diseases, including anaphylactic shock. Studies of the human IgE molecule, and its targeted allergens, have
been very limited. Nearly all of our knowledge of this process has come from studies using allergic patient serum, which
contains a complex mixture of antibodies, with different specificities, directed toward numerous epitopes, and having
dissimilar affinities; thus, studies of the molecular interactions of IgE with target allergens using serum are greatly
limited. The ideal way to study this process is to use naturally occurring human IgE monoclonal antibodies (mAbs),
isolated from allergic subjects. Unfortunately, due to many intrinsic technical hurdles, particularly the scarcity of these
cells in the circulation, no such antibodies could be made until now. We have established two unrelated methods to obtain
sequences of IgE encoding B cells from the peripheral blood of allergic individuals. In this proposal, we develop an
extensive first ever panel of naturally occurring alpha-gal specific human IgE mAbs from subjects with alpha-gal
syndrome (also known as red meat allergy). We intend to comprehensively define the precise molecular basis for IgE-
mediated reactions to red meat, from both the allergen and the antibody perspective. We will begin by expanding our
preliminary panel of IgE antibodies, using both human hybridoma technologies and single-cell RNA sequencing,
obtained from peripheral blood B cells of highly characterized research subjects with alpha-gal syndrome. As these IgE
mAbs represent the B cells which are induced to undergo class-switch recombination, we will analyze their variable gene
sequences to allow for a keen understanding of the B cell population(s) underlying this allergic disease, providing great
insights needed to predict individuals’ risk of sensitization. By analyzing IgE mAb variable regions we will understand
the alpha-gal specific mAb repertoire in terms of clonality and diversity as a function of glycan specificity within and
between affected individuals. Next, we will precisely define critical molecular details of human alpha-gal specific IgE
binding and function using a variety of in vitro characterizations, including glycan microarrays, competition-binding
assays, kinetic measurements by surface plasmon resonance analysis, and cell-based functional assays. X-ray
crystallography will be used to determine structures for IgE clones in complex with glycans, thereby molecularly defining
the epitopes underpinning red meat allergy. Together, this proposal will provide comprehensive analyses to molecularly
define the glycan epitope targets of the human IgE B cell response, and the origins of the B cells themselves, which will
provide much needed details underlying the sensitization and development of hypersensitivity to alpha-gal to inform
diagnostic and therapeutic development.

Public health relevance
PROJECT NARRATIVE The IgE antibody provides the targeting specificity for the immune cells it arms, mast cells, basophils, and eosinophils, plays a causal role in allergy, and remains understudied for its fundamental function in defending us against parasites. A recently discovered tick-borne disease, alpha-gal syndrome, otherwise known as red meat allergy, has been expanding in prevalence, occurs when the IgE isotype of antibody is induced during the bite of a tick - directing the immune system to target a sugar molecule galactose-alpha-1,3-galactose, also present in red meat. A greater understanding of the fine details involved in IgE antibody induction and binding specificity to this alpha-gal sugar is needed to predict who is at risk of developing alpha-gal syndrome and to create new tools with potential diagnostic and therapeutic clinical uses.